Impact of histone serotonylation domain organization on neurodevelopment

Project Summary
Emerging evidence suggests chromatin mechanisms contribute to brain development, including organization of
H3 lysine 4 tri-methylation (H3K4me3) domains. Broad H3K4me3 domains are linked with cell-specific
transcriptional activation and are associated with synaptic signaling in neurons, where H3K4me3 spreading was
disrupted in postmortem prefrontal cortex (PFC) neurons from patients with autism spectrum disorders (ASD).
Thus, H3K4me3 breadth likely influences important neurodevelopmental processes, but how this occurs is
unclear. Spreading of H3K4me3 broad peaks is regulated, in part, by the enzyme Lysine methyltransferase 2e
(Kmt2e), where over 30 genetic variants - including a valine-to-isoleucine substitution at position 140 (V140I) in
its chromatin-reading PHD finger - were observed in individuals with symptoms related to intellectual disability
and developmental delay. Interestingly, H3K4me3 sits next to glutamine 5 that can be serotonylated, producing
the combinatorial histone post-translational modification H3K4me3Q5ser that further enhances permissive
transcription compared to H3K4me3 alone. Our preliminary data show that H3Q5ser enhances binding of Kmt2e
to H3K4me3 and ChIP-sequencing of H3K4me3Q5ser in embryonic forebrain identified broad H3K4me3Q5ser
domains that associate with neurodevelopment-associated processes. Thus, I hypothesize that Kmt2e
regulates brain development via organization of H3K4me3 broad domains, and that the neighboring
H3Q5ser influences such interactions. To specifically interrogate Kmt2e and H3K4me3Q5ser binding as a
regulator of broad peak organization, the mutant Kmt2eV140I, that contains a mutation at the site where H3Q5ser
would extend during H3K4me3 and Kmt2e PHD finger binding, was selected as a translationally relevant genetic
variant that can be used to assess the mechanistic impact of this interaction. In Aim 1, I will quantitatively assess
the binding affinity between H3K4me3Q5ser and Kmt2eWT vs. Kmt2eV140I PHD fingers as a crucial interaction in
the developing brain that may be disrupted in some pathologies, using peptide immunoprecipitation followed by
western blotting and isothermal titration calorimetry. In Aim 2, I will use CRISPR/Cas9 technology in diploid RPE1
cells to assess the impact of tagged Kmt2eWT vs. Kmt2eV140I knock-in vs. Kmt2e knockout on broad peak
distribution using H3K4me3Q5ser ChIP-seq, on Kmt2e recruitment using Kmt2e ChIP-seq, and on downstream
transcription using RNA-seq. In Aim 3, I will assess the impact of Kmt2e in developing brain by using in utero
electroporation to transfect artificial miRNA designed to specifically knockdown Kmt2e expression in PFC
progenitor cells, with simultaneous ‘rescue’ by adding back tagged Kmt2eWT vs. Kmt2eV140I transgenes, using
H3K4me3Q5ser and Kmt2e ChIP-seq as readouts of epigenetic normalization, RNA-seq to evaluate
developmental gene expression programs, and neuronal morphology analyses to assess Kmt2e impact on
synapse development. Together, these studies will provide valuable insight into a novel epigenetic mechanism
regulating neurodevelopment that may be perturbed in syndromes such as ASD.

Public health relevance
Project Narrative Brain development is a complex organizational process that can be disrupted by genetic variants, environmental perturbations, dysregulation of serotonergic signaling and more; necessitating research into the molecular mechanisms underlying these processes in order to understand the etiologies of neurodevelopmental disorders such as autism spectrum disorders (ASD). In this proposal, we employ a unique combination of in vitro and in vivo systems to investigate a novel epigenetic mechanism in which serotonin specifically recruits the chromatin regulator Kmt2e to restrict spreading of histone post-translational modifications across the gene body, a molecular phenotype that can impact gene expression programs and was disrupted in ASD patient brains. Our preliminary data indicate that this epigenetic process may regulate important developmental pathways in the brain that offers potential for mechanistic insights into the etiology of neurodevelopmental disorders such as ASD.